Cultural Adaptation of an Alcohol and Other Drug Use Treatment for Black Justice Involved Youth

PROJECT SUMMARY/ ABSTRACT
The goal of the proposed NIAAA K23 Mentored Patient-Oriented Research Career Development Award is to
support Dr. Brittany Bryant in gaining the knowledge, skills, and expertise required for the successful transition
from clinical practice to building a career as an independent clinical researcher focused on improving treatment
options for Black justice-involved youth (JIY). Black JIY are overrepresented in the criminal justice system due
to institutional racism and discrimination. The General Strain Theory posits that high levels of ethnic and racial
discrimination (ERD), paired with elevated levels of witnessing or experiencing police brutality, places Black JIY
at unique risk of increased alcohol and other drug use (AOD) as a means of coping with stressful events. Black
JIY report engaging in comorbid alcohol and cannabis use to achieve temporary respite from discrimination-
induced stress. While JIY engage in higher rates of comorbid alcohol and cannabis use compared to non-justice-
involved youth, overall, Black JIY are less likely to be diverted to substance use treatment programs, less likely
to engage in care after being released on probation, less likely to benefit from substance use treatment in terms
of reduced risk of recidivism, and are more adversely affected by early onset of AOD activity than White JIY. To
date, no known adolescent substance use treatment directly addresses ERD, the increased risk of AOD due to
ERD, or explicitly presents tools on how to appropriately respond to AOD and discrimination distress among
Black JIY. To address this problem, Dr. Bryant’s research program aspires to improve the understanding of 1)
the impact of ERD on adolescent AOD within the Black JIY population; 2) culturally adapt the evidence-based
Cannabis Youth Treatment Series (CYT) using the ADAPT-ITT model to address ERD, reduce AOD, and reduce
recidivism with input from Black JIY, parents, and community members; and 3) pilot the culturally adapted
intervention to assess feasibility, acceptability, and changes in substance use and discrimination distress. For
the duration of the award, Dr. Bryant will 1) increase her record of scholarly publications; 2) expand knowledge
and skills in mixed methods research and applied research methods; 3) develop expertise in effectively
conducting community-based research; and 4) obtain training in effectively culturally adapting evidence based
interventions. The training and mentorship afforded to Dr. Bryant will enhance her career development and long-
term goals of becoming an independent community-based clinical researcher focused on improving treatment
options, policies, and procedures to decriminalize substance use and prioritize diverting Black JIY to substance
use treatment. Moreover, the proposed project aligns with NIAAA’s strategic plan to 1) prioritize the development
of culturally appropriate interventions to prevent or reduce alcohol misuse and related consequences, 2) improve
the implementation, accessibility, and use of alcohol treatment tailored to the needs of individuals, and 3) raise
awareness about the effects of alcohol on health and well-being, while supporting an underrepresented woman
of color trained in AOD research.

Public health relevance
PROJECT NARRATIVE The nation continues to witness racially motivated encounters between the Black community and police officers. With 87% to 94% of Black youth reporting at least one event where they were racially discriminated against in the past year, Black justice-involved youth (JIY) are exposed to discrimination more often due to policing, placing them at an increased risk of engaging in alcohol and cannabis use as a means of coping with discrimination distress. In this project, Dr. Bryant aims to 1) examine the impact of racial discrimination on alcohol and other drug use, 2) create a culturally adapted substance use intervention for use with Black JIY, and 3) pilot the culturally adapted substance use intervention to assess changes in alcohol use and discrimination distress among Black JIY.